MODULATION OF THE EXPRESSION OF A MULTIDRUG RESISTANCE GENE

The focus of the laboratory continues to center around the problems of drug resistance. Four major areas are actively being investigated. They are (1) multidrug resistance mediated by P-glycoprotein, (2) Topoisomerase II resistance (3) non-P-glycoprotein taxol resistance and (4) cisplatin resistance.